The Amylin Dyshomeostasis Hypothesis of Vascular Contributions to Cognitive Impairment and Dementia (VCID)

Alzheimer's disease (AD) is the most common cause of cognitive impairment, but diseases of cerebral blood
vessels, particularly the small blood vessels that supply all cells of the brain, are also major contributors. No
effective therapies exist, and innovative approaches are needed. The proposed study introduces two conceptual
innovations to identify novel therapeutic strategies. First, the study focuses on cerebral small vessel ischemic
disease (SVID) induced by dyshomeostasis of amylin, an endocrine hormone that participates in the central
regulation of satiety and also known to form pancreatic amyloid in patients with type-2 diabetes. Recent empirical
findings advanced in part by our group suggest that axonal degeneration and maladaptation of small vessels,
such as gliosis, are linked by vascular deposits of amylin. Our preliminary data also show that amylin deposition
in brain capillaries correlates with accumulation of amylin in red blood cells. Working in non-AD rats, we showed
that pancreatic expression of human amylin (rat amylin is non-amyloidogenic) promotes vascular amylin
deposition leading to microhemorrhages, axonal degeneration and late-life onset neurological deficits. Second,
the study introduces a new paradigm that amylin dyshomeostasis modulates brain amyloid composition. Several
laboratories (including ours) report the presence of mixed amylin-β amyloid (Aβ) plaques in brains of individuals
with pathological AD. To study the amylin-Aβ interaction in vivo, we crossed AD rats with human amylin-
expressing rats. Our preliminary data indicate that human amylin-expressing AD rats have accelerated aging
and behavioral changes, whereas genetic or pharmacological suppression of amylin is protective. Here, we
propose to test these hypotheses by using red blood cell lysates, cerebrospinal fluid samples and clinical data
from the MarkVCID study, along with mechanistic studies and amylin-centric therapeutic interventions in rat
models of amylin dyshomeostasis-related dementia. Data derived from the proposed specific aims can directly
lead to human clinical translational studies for the prevention and treatment of vascular cognitive impairment
and/or mixed pathologic disease states that currently lack effective treatments.

Public health relevance
Most patients with late-life onset Alzheimer's disease (AD) have cerebral small vessel ischemic disease; currently, there is no treatment or effective prevention strategies. We will focus on a specific endocrine hormone, which when hypersecreted, causes diabetes and interaction with AD pathology. If our study demonstrates that the specific hormone we are studying causes cerebral small vessel disease, then new inhibitors of this hormone should help protect the brain in aging and diabetes.